Predictive Analytics in Hemodialysis: Enabling Precision Care for Patient with ESKD

Machine learning (ML) based clinical prediction models (CPMs) have proliferated over the past
few years, becoming a central component of healthcare. These tools show great promise in
informing both providers and patients of impending health outcomes, ultimately allowing for
greater personalization of patient care. In our parent R01 we are developing a ML based mortality
prediction model for patients undergoing hemodialysis. The goal of this tool is to predict both short
and long term mortality risk in order to promote shared decision making between patients and
providers. Importantly, there are a number of ethical concerns inherent in ML based CPMs. These
include consideration of ethical performance (i.e., algorithmic bias), ethical usage (i.e., ensuring
outputs are properly interpreted) and ethical implementation (i.e., the tool is properly integrated
into the clinical workflow. For this current NOSI we propose to explore questions of ethical usage
of ML based CPMs. To do this, we will conduct focus group of patients & their caregivers,
providers and data scientists. We will address questions of trust in ML based CPMs,
understanding of risk and optimal risk communication, interaction with CPMs and AI/ML tools and
usage of CPMs to empower patients and promote shared decision-making. We will compare
responses across constituencies. We will use our findings to develop practice oriented guidances
that target both develops and users of ML based CPMs.

Public health relevance
There are many ethical concerns inherent in the usage of machine learning based clinical prediction models. We will conduct focus group of providers, patients and data scientists to understand the ethical usage of a mortality based prediction model for patients undergoing hemodialysis. We will disseminate our findings to via practice oriented guidances targeting both developers and users of clinical prediction models.